Philadelphia Regional Center for Children's Environmental Health

Administrative Supplement Project Summary
The Administrative Supplement of the Philadelphia Regional Center for Children’s Environmental Health
(PRCCEH, P2CES033428) will support the mission of research, training, and translation on climate change and
children’s environmental health. We will expand the existing thematic areas on lead exposure and harm reduction,
asthma, air pollution, and endocrine disrupting chemicals (EDCs) to include a new area on climate change. In
the supplement, we will achieve three specific aims: 1) to investigate the role of ambient temperature, heat index,
and air pollution on birth outcomes and placental health; 2) to enhance the capacity of early stage investigators
(ESIs) and trainees on the research and translation in the area of climate change and child health; 3) to develop
and implement translational products on climate change and pregnancy, neonatal, childhood health outcomes
to reduce the impact on pregnant people and children. In Aim 1, we will have two sub-aims: 1a) climate change,
air pollution, and preterm birth and small-for-gestational-age using Pennsylvania birth registry data 2010-2020;
1b) climate change, air pollution, and placental health using the existing data and biospecimen from Hospital at
University of Pennsylvania. In Aim 2, we will organize a workshop to enhance research capacity in the PRCCEH
on climate change and children’s health, provide pilot funding support for research and developing translational
products, and enhance diversity, equity, and inclusion activities for climate change research and translation. In
Aim 3, we will develop and implement new translational products for clinical and community use, address
community concerns on heat action plan, and include climate change workshop for public school teachers with
a focus on children’s environmental health. The supplement will support four Core Pillars of Climate Change and
Health Initiative (CCH) at NIH: Health Effects Research, Health Equity, Intervention Research, and Training and
Capacity Building. It will strengthen the PRCCEH research and translation activities to provide useful tools and
information to the communities affected by climate change.

Public health relevance
Administrative Supplement Project Narrative The Philadelphia Regional Center for Children’s Environmental Health (PRCCEH) will use the administrative supplement to conduct research, training, and translational activities on climate change and children’s environmental health. The supplement will bring new research findings on climate change and air pollution and perinatal health, motivate new investigators to expand research and translation on climate change, and provide clinicians and community members useful information and tools to reduce the impact of climate change on child health.